Creating the Next Generation of Scholars in CM Science (CMT32)

Project Summary
Child maltreatment (CM) is a costly and significant public health problem affecting millions of youth and
families each year. To date, no systematic training program exists that addresses the transdisciplinary scope
nor the full nature of this complex problem. Consistent with the strategic aims of NICHD, the proposed CMT32
is designed to nurture and develop the next generation of transdisciplinary scholars who will devote their
careers to CM science. Housed at Penn State, the CMT32 leverages the infrastructure, projects, and cores of
the P50 Capstone Center “Translational Center for Child Maltreatment Studies (TCCMS)” as well as the Child
Maltreatment Solutions Network (CMSN)—13 core program faculty across 5 Colleges from the fields of clinical
child psychology, human development, sociology, biobehavioral health, pediatrics, educational psychology,
nursing, and developmental psychology—to guide trainees in four topical training tracks: biological embedding,
developmental processes, prevention and treatment, and policy, administrative data and systems research. In
addition to immersion within and across substantive tracks, training in ethics, innovative methods, translation to
policy and practice, and community engagement is emphasized. Aided by an experienced Advisory Board, the
MPIs (Program Director of Training, Jackson and Program Director of Research, Noll) along with training Track
Leads and mentoring teams will execute a comprehensive training plan consisting of: coursework, seminars,
immersion learning, research productivity, community engagement, training in responsible conduct, peer
support, and policy activities. With devoted efforts to attract a diverse group of pre and post doc trainees, the
CMT32 will prepare the next generation of scholars to transcending siloed approaches in favor of
transdisciplinary team-science to solve to complex problem of CM.

Public health relevance
PROJECT NARRATIVE Child maltreatment is a significant public health issue affecting millions of youth and families every year. To date, there are no systematic training programs that address the need to expand child maltreatment science across the wide range of disciplines relevant to child maltreatment. The CMT32, using a transdisciplinary approach, will integrate training in child maltreatment across four tracks of training: biological embedding, developmental processes, prevention and treatment, and policy, administrative data systems to create pre and postdoc scholars who are fully equipped to contribute to the complex nature of child maltreatment science.